Interaction between circadian and sleep circuits

Project Summary
The goal of this proposal is to determine how the timing of sleep is controlled. Although the circadian clock
drives the 24 hour rhythmicity of sleep, the onset and duration of sleep is also determined by the extent of prior
wakefulness. The latter represents homeostatic control, which ensures that an organism gets enough sleep. In
a daily cycle, circadian and homeostatic systems are aligned, so sleep occurs at night following a day of
wakefulness. However, sleep loss at night or aspects of modern lifestyles, such as shiftwork or jetlag, can
cause misalignment of circadian and homeostatic systems. For instance, following a night of sleep deprivation,
homeostatic mechanisms will drive sleep in the morning although it is a time of circadian arousal. Even under
these conditions, the circadian system influences sleep and so will curtail the amount of sleep a night shift
worker might get during the day. Thus, interactions between circadian and homeostatic systems occur
constantly and are poorly understood.
Using a Drosophila model, we have dissected circuits by which the central brain clock controls rhythms of
locomotor activity. We now find that specific circadian output neurons we identified make contact with loci that
mediate homeostatic control of sleep. Our data suggest that the sleep homeostat suppresses circadian arousal
signals to allow sleep at the wrong time of day, e.g. in the morning following a night of sleep deprivation. In
addition, we find a rhythm of calcium in cells of the sleep homeostat as well as circadian regulation of their
sleep output. Rhythmic sleep output could be due to parallel effects of specific clock neurons, which drive
arousal at specific times of day, but together with the daily modulation of neural activity (calcium) in sleep
homeostatic cells, these findings provide us with a handle to determine how circadian signals are integrated
with homeostatic cues. To address the mechanisms by which these systems control the timing of sleep, we
propose to: (1) Determine how and when cells of the sleep homeostat act on circadian output neurons to
suppress arousal; (2) Determine how circadian and sleep signals are integrated in circadian output neurons.
As these output neurons also feedback to clock neurons, they play a critical role in linking the circadian and
homeostatic systems; (3) Determine how the clock interacts with light and homeostatic signals to modulate the
output of sleep homeostatic neurons.
Misaligned and disrupted sleep cycles have severe health consequences, including neurological disorders
such as stroke, so we expect this work to have broad medical relevance.

Public health relevance
Narrative The timing of sleep depends upon the coordinated action of two different systems in the body, the endogenous circadian system that imposes a 24 hour rhythm and the homeostatic system that ensures an organism gets enough sleep. This proposal will determine how, on a cellular level, the circadian and homeostatic systems interact to control the timing of sleep. It will allow us to understand why misaligned sleep cycles, which are common in modern society (e.g. due to shiftwork or jetlag), are associated with severe health consequences, including neurological disorders.